Washington University Nutrition Obesity Research Center

PROJECT SUMMARY/ABSTRACT – OVERALL COMPONENT
This application seeks continued funding for the Washington University (WU) Nutrition Obesity Research
Center (NORC). Since our NORC was first funded in 1999, it has served as a nidus for the growth and
development of nutrition and obesity research at WU. The infrastructure provided by the NORC has created an
environment that supports and stimulates cost-effective and high-quality research, collaborations between
investigators, training and career development in nutrition and obesity. Our NORC has a talented and diverse
research base consisting of 114 investigators (86 Regular Members and 28 Associate Members) from 3
different schools (School of Medicine, Brown School Program in Public Health, and the College of Arts and
Sciences) and 18 different departments within the School of Medicine. These investigators have 169
nutrition/obesity-related grants, generating $72.6 million/year in direct costs; 94% of NORC Regular Members
have NIH funding and 90% of total grant support is from Federal sources. The major research themes of the
WU NORC are: 1) Obesity: Pathophysiology, Complications, and Therapeutics and 2) Nutrient Metabolism in
Health and Disease. In addition, newly emerging areas of major interest include: 1) Community Health; and 2)
Gut Microbiome. We propose an Administrative Core, a Pilot and Feasibility (P&F) Program, which
provides four P&F awards/year to junior faculty and helps mentor them on their projects and careers, and 4
Biomedical Research Core laboratories: 1) the Clinical Science Research Core, which provides assistance
with: i) design and performance of complex metabolic studies, ii) body composition assessments, iii)
acquisition of adipose tissue and muscle samples, v) cardiovascular assessments, vi) exercise and physical
performance testing, vii) lifestyle interventions, vii) assessment of substrate kinetics in vivo by using stable
isotope tracers, viii) mathematical modeling of tracer and non-tracer data, ix) plasma substrate and hormone
concentrations, and x) biostatistical support; 2) the Animal Model Research Core, which provides: i) training
in breeding and animal husbandry, ii) biochemical and molecular analyses of blood and tissue samples, iii)
body composition analyses, iv) genotyping, and v) metabolic phenotyping; 3) the Cellular and Molecular
Biology Core, which provides: i) adipose tissue morphology, ii) adipocyte and muscle cell lines for culture, iii)
gene and protein expression, iv) mitochondrial physiology, v) extracellular vesicle isolation, and vi) training in
specialized research techniques, and 4) the new Dissemination and Implementation Science Core, which
provides services to help NORC investigators incorporate dissemination and implementation science into their
research programs to help advance the translation of their scientific discoveries to improve health outcomes
and promote equity among diverse populations. The collaborative interaction among our NORC research base
and our four Core laboratories encourage interdisciplinary approaches to address important issues in nutrition
and obesity.

Public health relevance
PROJECT NARRATIVE – OVERALL COMPONENT Obesity and its complications and nutrition-related diseases are a major public health problem because of their high prevalence, effect on quality-of-life and economic impact. The NORC will help reduce this burden by enhancing and stimulating cost-effective research in nutrition and obesity that will ultimately lead to improved clinical therapies and effective community interventions.